Multiscale investigation of cardiomyopathy-associated mutations in metavinculin

Project Summary/Abstract
Familial cardiomyopathies are genetic heart diseases that involve ventricular remodeling and altered cardiac
contractility. These diseases are often caused by mutations in proteins within the sarcomere, the fundamental
contractile unit of cardiomyocytes. Mutations in non-sarcomeric proteins involved in mechanotransduction, the
process by which cells sense and respond to mechanical force, have also been implicated in cardiomyopathy
but have received considerably less attention. For instance, studies of human patients have identified
cardiomyopathy-associated mutations in metavinculin, the muscle-specific isoform of the ubiquitous
mechanotransducer vinculin, but how these mutations lead to the disease phenotype is not well-understood.
Structural studies have shown that the 68-amino acid insert that differentiates metavinculin from vinculin replaces
the first alpha-helix in the actin-binding vinculin tail domain. Although this alpha-helix does not directly bind actin,
the metavinculin insert results in drastic changes of the organization of actin filaments by metavinculin compared
to vinculin, suggesting an allosteric effect on actin binding. The proposed research will test the hypothesis that
the pathogenic mechanism of cardiomyopathy caused by mutations in metavinculin involves disruption of cardiac
mechanotransduction through impairment of the force-dependent binding of metavinculin to actin. Single-
molecule force measurements of metavinculin binding to actin will directly address whether force stabilizes
binding of metavinculin to actin, as has been previously demonstrated for vinculin, as well as the effect of
pathogenic mutations on this force-dependent binding. The cellular consequences of altered force dependence
of metavinculin-actin binding will be investigated in stem cell-derived cardiomyocytes that carry the disease-
causing mutations using live-cell imaging of sarcomerogenesis (the establishment of new sarcomeres) and
traction force microscopy. These experiments will also be carried out on metavinculin-null cardiomyocytes to
elucidate the role of metavinculin in sarcomerogenesis and cellular contractility. The training provided under this
fellowship will take place at the Washington University School of Medicine, a world leader in biomedical education
and research. The proposed research aligns with the strategic objectives of the NIH by addressing the normal
biological function of metavinculin and the pathobiological mechanism underlying the onset and progression of
cardiomyopathy caused by mutations in metavinculin. In addition, the proposed training plan will contribute to
the strategic objective of developing a scientific workforce capable of accomplishing the NIH’s mission by
supporting the development of research, teaching, and professional skills required for the PI to establish a
successful independent research program in the field of cardiac mechanobiology.

Public health relevance
Project Narrative Studies of human patients have identified cardiomyopathy-causing mutations in metavinculin, a force-sensing protein expressed exclusively in muscle cells. The proposed research addresses the muscle-specific role of metavinculin and the impact of these disease-causing mutations at the molecular and cellular levels. These studies will enhance our understanding of the role of metavinculin in the heart and how mutations in metavinculin lead to cardiac disease, as well as potentially set the stage for the development of novel therapeutics.